Synthetic organogenesis: new paradigms in reconstituting human organ development in vitro

PROJECT SUMMARY
Organogenesis is a process in which biochemical signals and mechanical cues transform embryonic germ layers
into organs during fetal development. With recent advancements in stem cell biology, it has become possible to
differentiate human pluripotent stem cells into expandable 3D tissues that contain many of the cellular and
functional characteristics of fetal organs. These so-called organoids hold a tremendous potential to answer
longstanding questions of human organogenesis and to one day serve as a renewable source of patient-specific
human tissues. However, human organoids still only approximatively recapitulate organogenesis as they rely
on spontaneous tissue self-organization and the establishment of signaling gradients in unpredictable ways.
Furthermore, available organoid protocols focus on single organs and do not focus on morphogenesis. We be-
lieve that making a meaningful progress in the field demands 1), gaining a deeper understanding of the coupling
between signaling networks, tissue-specific transcriptional signatures, and tissue morphogenesis and 2), devel-
oping novel cross-disciplinary tools that control spatiotemporal signaling to accurately mimic organogenesis in
vitro. This proposal aims precisely to advance these gaps in our knowledge. We focus on the organogenesis of
the gut tube, the embryonic structure on which many adjacent organs form, from thymus and lungs to the colon.
Breaking away from the current organoid paradigms, which heavily rely on self-organization and the establish-
ment of often uncontrolled internal gradients, we will combine tissue micropatterning and microfluidics to gen-
erate precise signaling gradients so to reproducibly mimic both the signaling and the morphogenesis of gut tube
organogenesis in vitro. Combined with live-cell microscopy, CRISPR editing, and single cell transcriptomics our
organoids will reveal a detailed hierarchy of fate choices cells make from pluripotency to regionally specialized
tissues in the gut tube, and they will allow us to make crucial connections between signaling, transcriptional
regulation, and tissue morphogenesis. Our work will shed light on the largely unknown regulatory mechanisms
by which the complex signaling pathways interact to create asymmetric patterns along the body axes. For the
first time, our approach will recapitulate the formation of multiple adjacent gut tube progenitors from an em-
bryonic germ layer, providing a unique window into one of longstanding questions in developmental biology:
how do continuous signals create discretely separated organs along body axes? Finally, in collaboration with
CRISPR experts, we will generate a pipeline that bypasses traditional morphogen-driven differentiation of plu-
ripotent cells, but instead uses inducible genetic circuits to mimic fate decisions. This novel system will have the
capacity to generate highly precise human tissues on the fly, in an approach that can be termed synthetic organ-
ogenesis. Our proposed work will open routes to studying long elusive molecular mechanisms of early human
organogenesis and start bridging the crucial gap between organoid biology and regenerative medicine.

Public health relevance
PROJECT NARRATIVE Understanding how cells in the embryo interpret complex signals to create organs is one of the most challenging and important questions in biology. We propose to develop in vitro models of organ development by combining human stem cells, advanced tissue engineering, and genomic editing techniques that will allow us to study de- tailed molecular mechanisms of organ formation in the human gut, from the lungs to the large intestine. The proposed work will significantly advance the current paradigms in stem cell biology and will innovate technol- ogies of recreating precise human organ tissues in a lab, and eventually enable high-throughput drug screening, and physiological modeling of gut homeostasis, chronic inflammation, and infections.